Leveraging Health Systems to Increase Implementation of Evidence-based Surgical Cancer Care

PROJECT SUMMARY
Hospitals are increasingly consolidating into health systems with shared ownership and management. Care in a
health system has potential benefits for surgical cancer patients including improved access, care coordination,
and strategies to disseminate and implement a rapidly evolving evidence-base into practice across system hub
and spoke sites. Prior research has demonstrated that these potential benefits remain elusive. The impact of
consolidation on quality varies widely, and there are disparate outcomes for surgical cancer patients treated at
different facilities in the same systems. We have shown that location of surgical cancer care determines whether
effective treatments are adopted (implementation) or ineffective treatments discontinued (de-
implementation). We hypothesize that health system characteristics and strategies are associated with variability
in implementation of oncologic evidence among hub and spoke hospitals and that through exploration of
observed differences we will identify levers for targeted, multi-level interventions.
This work addresses the NIH Blueprint objective to enhance research investments by ensuring adoption into
practice and targets rural individuals, a population with disparate healthcare access and outcomes, who are
often treated at spoke hospitals. We will examine the influence of treatment for common cancers in health system
hubs and spokes on patient access and receipt of evidence-based care by linking SEER-Medicare data with
health system data. Then, we will identify health system characteristics associated with evidence
implementation, both quantitatively using multilevel modeling and qualitatively through structured interviews with
health system stakeholders. Finally, we will use the resources within our Health System at the University of
Alabama at Birmingham (UAB) to develop a system-level intervention for dissemination and implementation of
oncologic evidence across hub and spoke sites.
My long-term goal is to become an independent investigator who improves the quality of cancer care delivery by
designing, implementing and studying health system-level interventions to increase clinical adoption of oncologic
evidence. Through this training award, I will complement my health services and quality improvement science
expertise with advanced training in the organization of healthcare delivery, multilevel analysis of secondary data,
and implementation science to develop a system-level intervention to improve evidence-based surgical cancer
care.

Public health relevance
PROJECT NARRATIVE Most patients with common cancers in the United States receive surgical care within health systems, but quality is inconsistent across system hub and spoke sites. This project will evaluate the effect of treatment in a health system hub or spoke on receipt of evidence-based surgical cancer care and will identify health system characteristics and strategies that are associated with system performance and consistency across sites. The product, an intervention map for system-level implementation of oncologic evidence, can be used by health systems to provide consistent, high-quality care across sites, increasing equity in cancer care delivery.